Administrative Core

CORE SUMMARY – ADMINISTRATIVE CORE
The proposed Faculty Initiative for Improved Recruitment, Retention and Experience (FIIRRE) seeks
to expand the diversity of our health sciences faculty and transform the culture, policies, and practices of the
University of South Carolina (UofSC) to promote inclusive excellence. The Administrative Core, led by MPIs
Angela Liese from the Arnold School of Public Health and Coretta Jenerette from the College of Nursing, will
ensure the full integration of all FIIRRE cores, drawing strong administrative, intellectual and fiscal support
from our institutional leadership, Internal and External Advisory Councils and other core personnel. Serving as
the nucleus of FIIRRE at UofSC, the Administrative Core will: 1) provide the organizational structure, senior
leadership, and infrastructure necessary to enable the success of all core goals, 2) oversee the administrative
and financial operations of FIIRRE, including recruitment and retention of a cohort of ten new tenure-track
Assistant Professors who are committed to inclusive excellence and conduct health disparities and
equity research, 3) advocate for FIIRRE and serve as a liaison to institutional leadership, funders and other
stakeholders, and 4) identify and redress ways in which current policies and practices foster racial bias
and other forms of discrimination at all levels of the institution, including tenure and promotion. Our leaders are
interwoven into key leadership positions and decision-making committees within the institution, enabling our
team to introduce and help advance key policy and practice change recommendations from the “ground up”. In
addition, FIIRRE builds off the substantial institutional investments made towards inclusive excellence
at UofSC in the past five years, including a Strategic Plan “A Path towards Excellence” that prioritizes diversity
and inclusivity at all levels: executive, faculty, staff and student. Working closely with the Office of the Provost
and Office of Diversity, Equity and Inclusion at UofSC, as well as other FIRST awardees and the Coordination
and Evaluation Center, the Administrative Core will organize and manage FIIRRE’s many distinct activities,
processes and outreach efforts.